MOLECULAR BIOLOGY INFRASTRUCTURE FOR BIOMEDICAL RESEARCH

DESCRIPTION: The goal of the planning process, Phase I, is to prepare for the establishment of a WSSU RIMI Center. The developed plan will be institutional and consistent with the mission and authority of WSSU as stated in its Long Range Plan of 1994 - 99. High priority will be given to the biomedical research support areas. The specific aims of Phase I will deal with identification of administrative offices and offices for support staff. Support areas needed will be named and mechanisms to acquire such support areas will be defined; faculty in the three health related science departments will be evaluated in terms of interest and biomedical research capability and appropriate faculty development activities will be planned; a uniform formal Memorandum of Understanding Agreement will be designed and enacted with existing and new collaborating research-intense Ph.D. degree granting universities, and a similar form will be used with collaborating industries; and pilot biomedical research proposals will be solicited and evaluated. Planning will be guided and monitored by an Advisory Committee with members from WSSU, biomedical research- intense Ph.D. degree granting institutions and health-related industries.